Mitochondrial Dynamics in Female Reproduction

PROJECT SUMMARY
Mitochondrial fitness is critical for their proper functions in diverse cellular and developmental processes.
Strong evidence links mitochondrial dysfunction to reduced fertility in humans. However, the mechanism
underlying these connections, and whether any potential treatments of such mitochondrial defects may
remedy these infertile cases, remain unknown. Mitochondrial features, activities, and functions are tightly
regulated via mitochondrial fusion (mitofusion) and fission, collectively known as mitochondrial
dynamics. Accumulating evidence from somatic cells support that mitochondrial dynamics not only
enable coordinated responses of individual mitochondria to developmental stimuli and metabolic needs,
but also ensure mitochondrial fitness. In addition, increased mitochondrial dynamics reduce mutant
mitochondria in Drosophila oocytes, strongly suggesting conserved roles of mitochondrial dynamics in
regulating mitochondrial fitness in reproduction. In the parent R01 of this supplement study, we aim to
unveil novel functional mechanisms of how spermatogonial stem cell differentiation and male germ
cell mitochondrial fitness are regulated by properly balanced mitofusion and fission. We have generated
a series of genetically modified mouse models to achieve this goal but will only need male mice. On the
other hand, published studies suggest that mitochondrial dynamics conservatively regulate mammalian
reproduction in both sexes but via sex-specific mechanisms. Each mature oocyte contains about
100,000 mitochondria, 500-fold more than male germ cells, suggesting that very high mitochondrial
activities are needed to support female reproduction. Studies with conditional knockouts of either pro-
fusion or fission factors in female germ cells indeed support that mitochondrial dynamics are dispensable
for ovarian follicular reserve. This supplement study aims to unveil the role of mitochondria dynamics
in female fertility and underlying mechanisms, scientifically complementary to the parent R01. We will
cost-efficiently use female mutant mice from the same breeding process for the proposed experiments,
operationally complementary to the parent R01. Using mitochondrial DNA mutator mice and novel
mitofusion agonists, we will determine the functional impacts on female reproduction and mitochondrial
fitness by augmented mitochondrial dynamics. Study findings will fundamentally advance research in
both mitochondrial biology and reproductive medicine by revealing sex-based commonalities and
differences in the mitochondrial regulation of mammalian reproduction. Our study will also inform a novel
strategy to treat impaired female fertility due to mitochondrial dysfunction. Findings from this study will
significantly advance reproductive research related to women’s health, answering the call of this specific
“Administrative Supplement for Research on Sex and/or Gender Influences” and serving well the strategic
goals of the “2019-2023 Trans-NIH Strategic Plan for Women’s Health Research”.

Public health relevance
PROJECT NARRATIVE Infertility affects ~48.5 million couples worldwide, and strong evidence links mitochondrial dysfunction to reduced fertility in humans. This supplement project aims to discover novel mechanisms underlying female mitochondrial fitness regulated by mitochondrial dynamics. Study findings will provide critical insights into the poorly understood mitochondrial fitness during female germ cell development and may critically inform novel strategies to treat impaired female fertility due to mitochondrial dysfunction.